Safety and Efficacy Evaluations of Topical Microbicide/Biomedical Prevention Products in the Repeat Low-Dose Macaque SlV /SHIV Infection Model

The purpose of this agreement is to develop safe and effective biomedical interventions to reduce transmission of human immunodeficiency virus (HIV) and the burden of acquired immunodeficiency syndrome (AIDS) disease.